Leveraging Social Networks to Promote PrEP among Young Latino Sexual Minority Men

PROJECT SUMMARY
HIV disproportionately impacts Latino sexual minority men (SMM), particularly youth and young adults. HIV
incidence in young Latino SMM is in part driven by low uptake of pre-exposure prophylaxis (PrEP) due to
multilevel barriers. In my prior work, I led a community-driven media campaign entitled “PrEPárate” (“Be
PrEPared”) which promoted PrEP information and a website with affordable and bilingual options to access
PrEP. The campaign was associated with increased PrEP awareness and use but had limited reach to highly
marginalized young Latino SMM (e.g., those without insurance, those with limited English proficiency). In this
K23 career development award, I propose to develop, pilot, and evaluate a multilevel intervention that
combines a refined media campaign and peer-based strategy, informed by social network analysis. For youth
and young adults, social networks of peers and family are especially influential in decision making and present
an opportunity to promote PrEP among marginalized communities. Through this award, I will receive new
training and mentored experience in (1) social network analysis, (2) multilevel intervention development, and
(3) implementation science. This K23 will lay the groundwork for an R01 application to conduct a randomized
controlled trial studying the effectiveness of a multilevel intervention to increase PrEP use among young Latino
SMM. This proposal will advance understanding of how cultural and developmental factors shape young Latino
SMM social networks and also will help identify optimal strategies to address PrEP disparities for youth and
young adults. Through this training, I will gain the skills required to transition to independence as an
investigator with expertise in interventions to address HIV-related disparities among marginalized youth and
young adults.

Public health relevance
PROJECT NARRATIVE This proposal is an innovative multilevel intervention that combines a media campaign and peer-based strategy, informed by community engagement and social network analysis, to increase PrEP awareness and use among young Latino sexual minority men. This research will lead to a culturally and developmentally tailored intervention that can serve as a model for HIV prevention efforts in marginalized youth and young adults.